Depleting S1P to reverse immune exclusion for effective cancer immunotherapy

PROJECT SUMMARY
The overarching goal of this research proposal is to (i) demonstrate a completely novel approach for cancer
immunotherapy in which degradation of extracellular sphingosine-1-phosphate (S1P) enhances lymphocyte
trafficking to and infiltration of tumors, especially those that are known to exclude and/or strongly suppress
cytotoxic T cells and (ii) generate a developmental candidate therapeutic S1P degrading enzyme suitable for
subsequent clinical development. Patients with tumors that have a “cold”, “immune excluded”, or “immune
desert” phenotype typically have poor outcomes on immune checkpoint therapy (ICT). These immune “cold”
tumors often result from impaired trafficking of lymphocytes from the sentinel lymph nodes into circulation.
Extracellular S1P, a bioactive lipid arising from the tumor and/or tumor draining lymph nodes (TDLN) appears to
play a significant role in blocking tumor specific T cell circulation and infiltration by stalling or sequestering
lymphocytes in the TDLN, keeping T cells from entering circulation and migrating to tumors. Along these lines,
elevated S1P synthesis arising from tumoral upregulation of a kinase that generates S1P, SPHK1, strongly
correlates with resistance to immunotherapy and poor patient survival in multiple tumor types.
In preliminary studies, we developed a prokaryotic S1P degrading enzyme tool compound (StS1PL) and
demonstrated in murine cancer models that treatment with StS1PL depletes extracellular S1P, dramatically
increases the accumulation of activated T cells in tumors, and strongly or completely inhibits tumor growth when
administered as a single agent. We found that the anti-tumor effects of StS1PL strongly depend upon CD8+ T
cells and that the CD8+ T cells found in the tumor are antigen-specific and appear highly activated. The work
proposed here will test the hypothesis that the reduction of extracellular S1P is a powerful modality for releasing
tumor specific T cells from TDLNs, allowing them to recirculate and enhance tumor immune surveillance.
Through this work, we will determine if immune “cold” tumors can be made responsive to immunotherapy (Aim
1), and we will elucidate mechanisms by which S1P reduction facilitates T cell activation, differentiation,
redistribution between tissues, and trafficking to the tumor microenvironment (Aim 2). Successful completion of
these studies will yield a tractable strategy for treating tumors that are refractory to immunotherapies, as well as
a more detailed understanding of the process by which impaired trafficking of T cells may occur. We also expect
to deliver an optimized human therapeutic enzyme displaying the requisite catalytic function and pharmacological
properties (stability, PK/PD) for subsequent clinical evaluation (Aim 3).

Public health relevance
PROJECT NARRATIVE The overall goal of this work is to develop and characterize a therapeutic that stimulates cancer killing lymphocytes (T cells) to infiltrate tumors and eradicate them; we believe this will address the clinical findings that an immune “desert”, or lack of proximity between cytotoxic immune cells and tumors, results in profound resistance to cancer immunotherapy. Abnormal signaling by sphingosine-1-phosphate (S1P, a potent bioactive lipid) in tumors and tumor draining lymph nodes (TDLN) causes a form of immune “desertification” that keeps anti-tumor immune cells from leaving the TDLN. We have found that therapeutic enzymes that deplete extracellular S1P, dramatically increase the trafficking of lymphocytes out of TDLNs, increase tumor T cell infiltration and strongly or completely inhibit tumor growth when administered as a single agent.